Combined Fluorescent and Gold Labeling Reagents

Correlative light and electron microscopy (CLEM) is an essential tool for correlating structure and function at
the cellular level with the localization and mechanism of processes at the macromolecular level. New
fluorescence labeling technologies such as brighter, sharper fluorophores, fluorescent fusion proteins and
spectral deconvolution afford highly multiplexed mapping, superresolution microscopy has enabled more
precise target localization and methods such as FRET localize nanometer-range molecular interactions.
Meanwhile, new instrument and workflow designs and large-volume methods have greatly expanded the scope
of electron microscopy and our ability to correlative EM and LM data. However, a lack of truly correlative,
multiplexed labeling technologies has prevented realization of its full potential. We will address this unmet
need by systematically developing a set of reagents that combine fluorescence tags with a gold nanoparticle EM
label in a single reagent that can be used to label any appropriately reactive molecule in one simple reaction.
We will use monodisperse biocompatible macromolecules as spacers to separate the fluorescent and gold
labels, thus minimizing fluorescence quenching and incorporated the reactive group for probe labeling into the
gold nanoparticle to ensure highest possible EM labeling precision. Spacers of different sizes will be used to
prepare reagents using three different gold nanoparticle sizes – 1.4, 3, and 5 nm – each combined with
different fluorophores. Reagents will be developed both with biorthogonal reactivity (Click, Snap and Halo-
Tag) and with specific reactivities towards functional groups such as thiols and amines for conventional
conjugation reactions with molecules such as peptides, nucleic acids, lipids, substrate analogs or inhibitors.
Reagents will be evaluated in two experimental systems:
(1) Correlative fluorescence and Chromatin electron microscopy tomography (ChromEMT) to label, map, and
differentiate the 3-D distribution of the three major structural classes of chromatin: (a) transcriptionally active
regions, (b) transcriptionally repressed chromatin, and (c) bivalent/transitionally silent regions (collaboration
with Dr. Antonio Giraldez and Dr. Alice Sherrard of Yale University Medical School).
(2) Correlative fluorescence and electron microscopic labeling of alpha-synuclein (a-syn) aggregates to
elucidate their uptake by neurons using FRET, FIB-SEM, pre and post-embedding EM and electron
tomography (consulting collaboration with Dr. Eduardo Rosa-Molinar, Washington University in St. Louis,
Center for Cellular Imaging).

Public health relevance
Research tools will be developed to expand and enable new approaches to the study of biological structures in cells, tissues, organs and organ systems. Products will be developed that will enable the correlation of light microscopy data to map the distribution and interactions of key molecular targets at the cell, tissue and organ level with ultrastructural localization by electron microscopic methods at macromolecular resolution. These will help realize the full potential afforded by correlating different microscopies to our understanding of the mechanisms of normal and disease processes.